High-Performance Gradient Coil for 7 Tesla MRI

PROJECT SUMMARY/ABSTRACT
This application seeks to upgrade an existing 7 Tesla human MRI scanner at the Athinoula A. Martinos Center
for Biomedical Imaging. The proposed upgrade consists of newly available high-performance head gradient
coil, the most powerful of its kind—with maximum slewrate of 700 T/m/s and strength of 200 mT/m, more than
twice that of the most advanced gradient coils in regular use today. This innovative gradient coil, the "Impulse",
was designed exclusively for 7T by Siemens with input from Martinos investigators, and has overcome the
performance limits of previous-generation gradient coils. It is currently in use only at one 7T site (UC Berkeley).
The key advantage provided by this gradient coil’s added performance is faster image encoding for brain
imaging. This can be utilized to improve image quality in many techniques, in particular echo planar imaging
(EPI), which is the workhorse method for functional imaging studies as well as diffusion, and perfusion MR
imaging. The higher performance will help reduce artifacts such as distortion and blurring, which are present in
EPI at these higher magnetic field strengths, and thereby enhance data quality for a broad range of
applications. The faster imaging speeds can also provide the necessary encoding for high-resolution functional
MRI (fMRI) within the limited time-window afforded by T2* signal decay. Although 7T provides a substantial
boost in fMRI sensitivity, and mounting evidence indicates that the intrinsic biological resolution of fMRI is well
below the millimeter scale, existing hardware platforms cannot achieve the imaging resolution desired for many
experiments—thus today, 7T fMRI is known to be “encoding limited”. This gradient coil will help surpass these
encoding limits to help reap the full potential of 7T fMRI. The high gradient strength combined with the high
slew rate of this gradient coil will also help enable diffusion MRI at 7T by reducing both the diffusion encoding
duration and image encoding times, which is typically challenged by rapid T2 decay at ultra-high field. The high
slew rate will also boost performance of advanced anatomical imaging methods like our “wave-CAIPI” method
that can achieve even higher acceleration factors with faster slew rates for high-resolution anatomical imaging.
The Martinos Center has vast experience with similar previous-generation head gradient coils. We have
the technical expertise to optimize performance of this powerful new gradient coil, and a team of engineers to
support the instrument and develop—and invent—new applications. Overall, this proposed upgrade will benefit
the broad user base within the Martinos Center and the many affiliated researchers within the Boston area who
use our facilities, providing investigators with a technological edge required for innovative clinical, translational,
and basic research. This exciting technology will enable new experiments and thus will likely generate new
funding support, and attract talented developers and new investigators. Finally, the success of this
instrumentation upgrade will help pave the way for other PHS-funded research centers to adopt this next-
generation gradient coil and help launch a community of researchers using this transformative new technology.

Public health relevance
PROJECT NARRATIVE This project proposes to upgrade a human 7 Tesla MRI scanner at the MGH/HST Athinoula A. Martinos Center for Biomedical Imaging. The upgrade will consist of a newly available high-performance gradient coil, provided by the scanner manufacturer, and designed exclusively for 7 Tesla MRI, that can achieve more than double the strength and three times the speed of the existing gradient coil. This transformative new technology will dramatically improve data quality and provide higher imaging resolutions than currently possible, enabling new experiments and innovations in basic, translational, and clinical research.